MEASURING EXERCISE TOLERANCE IN FRAIL OLDER ADULTS

The purpose of this agreement is to develop and test a set of measures and protocols to measure exercise tolerance and aerobic capacity for use in population- based studies of older adults; and to develop a method for scaling performance across tests. Hard copy records of examination results and raw data files will be delivered within 30 days of the completion of the last examination. Description and documentation of testing procedures, including reliability data, in a form suitable for scientific use will be delivered within 3 months of the last examination. This project is a 10- month commitment.UY